The oncogenic roles of alarmins and monocytes in triple negative myelofibrosis

PROJECT SUMMARY
Myelofibrosis (MF) is an aggressive chronic myeloid malignancy characterized by splenomegaly, impaired
hematopoiesis, bone marrow (BM) fibrosis, and has a high risk of transforming into acute myeloid leukemia
(AML). Recurrent driver mutations in JAK2 pathway genes (i.e., JAK2, CALR, and MPL) are commonly identified
in MF patients, and preclinical studies have shown these mutations lead to constitutive activation of the JAK2
pathway, chronic inflammation, and MF development. Accordingly, several JAK2 inhibitors have been approved
by the FDA based on their clinical benefit in ameliorating symptoms and improving overall survival (OS) in MF.
However, current JAK2 inhibitors are not disease modifying agents and subgroups of MF patients have inferior
response to these drugs, particularly triple negative MF (TN-MF) cases that lack JAK2 pathway mutations. Thus,
the field is focused on developing new therapeutic strategies to improve clinical outcomes in MF, especially TN-
MF.
MYC gene is located on chromosome 8 and MYC is a transcription factor that controls the expression of
genes involved in metabolism, cell survival and proliferation. Our studies and those of others have shown that
MYC plays oncogenic roles in AML and myelodysplastic syndrome (MDS). However, its role in MF pathogenesis
is largely unknown. My studies have identified a significant proportion of TN-MF cases have an additional copy
of chromosome 8 (trisomy 8) and that MYC expression levels are elevated in hematopoietic stem cells (HSC).
Further, modest levels of MYC overexpression in HSC provoked myeloid disease that is akin to MF, and the
development of MYC-driven MF requires upregulation of S100a9, an alarmin that plays critical roles in
inflammation and innate immunity. Of note, S100a9-mediated inflammatory signals predominantly affect
monocytes and macrophages (MΦ) through ALCAM and CD68 receptors, leading to a significant expansion of
these cell types. However, genetic deletion and pharmacologic inhibition of S100a9 did not abrogate all MYC-
driven MF phenotypes, indicating additional downstream targets of MYC are involved in MF pathogenesis.
These findings support the hypotheses that other targets downstream of MYC also contributes to MF and
that MYC-directed expansion of monocytes and MΦ contributes to MYC-driven MF. To test these hypotheses, I
will assess the contributions of Galectin-3 (Gal-3), an additional alarmin I identified as a MYC downstream target,
to MYC-driven MF (Aim 1). In addition, using both genetic and pharmacologic approaches, I will determine the
roles of monocytes and MΦ in MYC-driven MF (Aim 2). Collectively, my proposed studies will provide important
insights into MYC regulation of alarmin-mediated inflammation while simultaneously addressing unanswered
questions in the field of MF biology and therapy.

Public health relevance
PROJECT NARRATIVE Despite significant advances in our understanding of the underlying pathogenesis in myelofibrosis (MF) and the development of JAK2 inhibitors, clinical outcomes in MF remain dismal due to persistence of malignant MF clones in patients undergoing JAK2 inhibitor therapy, the development of drug resistance, and a high risk of transformation into acute myeloid leukemia. Accordingly, there is an urgent need to develop new therapeutic strategies targeting the molecular and genetic aberrations that drive MF clonal expansion, particularly in triple negative MF cases that lack JAK2 pathway mutations. This K22 research program focuses on (i) defining the roles of a novel MYC-alarmin circuit that I have shown is sufficient to provoke MF independent of JAK2 pathway mutations; and (ii) assessing the roles of monocytes and macrophages, two hematopoietic cell types that are predominantly affected by the MYC-alarmin axis, to preclinically determine the therapeutic potential of targeting this pathway and cell types to improve outcomes in MF.